Core C: Myeloid cell and atherosclerosis core

The Myeloid Cell and Atherosclerosis Core (Core C) within the Program Project “Triglycerides, Diabetes and
Cardiovascular Disease” will provide individual projects with analytical techniques for thorough analysis of
lesions of atherosclerosis from the different mouse models used within the program. These analyses will
include histological staining methods, lesion size measurements, lesion morphology characterization,
immunohistochemistry, and laser capture microdissection for analysis of gene expression. The core will also
provide expertise and bioinformatics analysis of RNA-sequencing and single cell RNA-sequencing data as a
complement to the Program Investigators’ projects. This Core’s repertoire of high-quality analyses of myeloid
cells, atherosclerosis and other tissues studied within the Program Project will substantially enhance the
scientific progress of the four individual projects.